The Interplay Between Negative Emotion Differentiation and Emotion Regulation Problems in Posttraumatic Stress Disorder

Project Summary/Abstract
Posttraumatic stress disorder (PTSD) is characterized by inflexible patterns of experiential, behavioral, and
physiological emotional responding. Following trauma exposure, the indiscriminate avoidance of trauma-
related cues contributes to the maintenance of PTSD, which tends to be chronic and associated with a myriad
of deleterious personal and public health consequences. Although inflexible emotional responding has been
identified as a critical maintenance factor for PTSD, less is understood about how trauma-exposed people fall
into these problematic emotion regulation patterns. Recent theory posits that the ability to differentiate between
discrete negative emotions allows individuals to extract emotion-related information to guide the effective use
of emotion regulation strategies in service of personal goals. When negative emotions are experienced with
less granularity, emotion information becomes less readily available and places people at risk for maladaptive
emotion regulation. Negative emotion differentiation (NED) has yet to be examined in the context of avoidance
in PTSD, however, or in relation to markers of physiological inflexibility that are believed to contribute to
emotion regulation problems across a range of clinical disorders, including PTSD. Thus, there is a need for an
integrated investigation spanning multiple units of analysis to understand how NED confers risk for emotion
regulation problems known to maintain PTSD. The objective of the proposed research is to elucidate whether
NED is impaired in PTSD and associated with avoidance and resting respiratory sinus arrythmia (RSA) – a
marker of physiological flexibility – in the lab and in daily life. Aims of the proposal include determining whether
NED is impaired among those with PTSD relative to those without PTSD (Aim 1), whether NED is associated
with self-reported trait avoidance and daily trauma-related avoidance (Aim 2), and whether NED is associated
with resting RSA in the lab and in daily life (Aim 3). Given that NED is believed to guide emotion regulation
strategy use based on the demands imposed by the environment, this project will also examine whether NED
moderates the links between avoidance and PTSD (Aim 4). These aims will be tested using data from an
ongoing NIH-funded study (1R15MH114142) of 80 trauma-exposed community members with and without
PTSD. PTSD diagnosis and severity, trait-level avoidance, and resting RSA are assessed in the lab and three
days of ecological momentary assessment and ambulatory physiological assessment are used to monitor daily
trauma-related avoidance, resting RSA, and PTSD symptoms. The proposed project will advance the field by
delineating associations between NED and emotion regulation problems across multiple units of analysis in
PTSD. Elucidating the interplay between NED and emotion regulation problems may also provide insight into
the etiology and maintenance of PTSD. As an NRSA F31 proposal, this project includes a training plan
consisting of formal coursework, workshops, experiential learning, and mentorship in PTSD, emotion dynamics
and regulation, autonomic psychophysiology, ambulatory assessment, and multilevel modeling.

Public health relevance
Project Narrative Posttraumatic stress disorder (PTSD) is a debilitating and chronic psychiatric illness associated with severe personal and public costs that affects approximately 6.4% of the U.S. population (~21 million Americans). Although PTSD is characterized by inflexible emotion regulation across experiential, behavioral, and physiological systems, little is known about how emotion regulation manifests into rigid response patterns that are crucial to the maintenance of this disorder. This proposal seeks to evaluate the interplay between negative emotion differentiation (NED), or the extent to which people discretely experience negative emotions, and self-reported avoidance and resting respiratory sinus arrythmia in PTSD using ambulatory assessment (i.e., ecological momentary assessment, ambulatory psychophysiology), and offers the potential to improve our understanding of how PTSD is developed and maintained over time.